Cancer Research Career Enhancement and Related Activities

PROJECT SUMMARY - CANCER RESEARCH CAREER ENHANCEMENT AND RELATED ACTIVITIES
Educating and training the next generation of leaders in cancer research is a key goal of the Wistar Cancer
Center. As Wistar itself is not a degree-granting Institution, the educational mission of the Cancer Center
focuses on dedicated partnerships with other institutions, matching the collaborative culture of inclusiveness
and team science that are hallmarks of the Cancer Center. Evolved over the years, the educational mission of
the Cancer Center is diverse in objectives and inter-institutional partnerships, running the gamut from a high
school program in partnership with the School of District of Philadelphia, to an undergraduate Biomedical
Technician Training (BTT) workforce development initiative in collaboration with the Community College of
Philadelphia, to various graduate and post-graduate training mechanisms together with neighboring
Universities. Support for Cancer Center educational activities comes mostly from peer-reviewed federal
funding, currently totaling 10 awards for $1.34 million, including a long-running National Cancer Institute (NCI)-
sponsored T32 training grant. During the last five years, significant investments were made to support an
expansion of Cancer Center education, as codified in the 2015 Reimagining Wistar Strategic Plan. These
included the recruitment of Brian Keith, Ph.D. as the new Associate Director for Education in the Cancer
Center and the first-ever Dean of Biomedical Studies at Wistar, an expansive physical plant renovation to
create dedicated classroom space and specific teaching laboratories, another “first” for Wistar, and extensive
online content development for the BTT program. Under the same inspiring criteria of inclusiveness,
collaboration and inter-institutional partnership, the expansion of Wistar Cancer Center education during the
next budget cycle of Wistar’s Cancer Center Support Grant (CCSG) will integrate the diverse educational
activities at the Cancer Center in a coherent and synergistic platform; double the size of the BTT program to
create a portable, scalable workforce development and job placement program in cancer research and the life
sciences in partnership with the Commonwealth of Pennsylvania; expand a Ph.D.-granting program in cancer
biology in collaboration with neighboring University of the Sciences (USciences), currently the only one in the
greater Philadelphia region, to create a stable pipeline of postgraduate trainees in cancer research; and enrich
the postdoctoral experience at the Cancer Center through a diversified portfolio of career and professional
development tools. The planned collaborative expansion of Wistar education will fulfill a critical strategic goal of
the Cancer Center in developing the cancer research workforce of the future.